REGULATION OF TRANSCRIPTS INVOLVED IN HUMAN ES CELL DIFFERENTIATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are analyzing pluripotent and neural human embryonic stem cells to determine changes in transcript abundances for the entire list of 800 glycan-related genes.